Using Static and Dynamic connectivity analyses of Eloquent brain tissue to assess surgical risk in patients with intractable seizures

We have completed the review of 41 healthy individuals who were recruited as part of the epilepsy seizure protocol. We have classified their performance on the various auditory language tasks conducted as part of the pre-surgical evaluation of language and neuropsychological assessments. We have performed the static and dynamic connectivity analyses of the auditory language networks on 8 of the 41 healthy control subjects who were found to have completed the same auditory language tasks, controlled for the level difficulty and who are matched for educational level and age. We have completed the analysis of both static and dynamic connectivity in all of the healthy individuals for both task based fMRI and resting state MRI imaging data. We are currently writing up our results which are the following: 1. We identified left-left networks, right-right networks and interhemispheric networks using the most conservative of statistical methods and after corrections for motion and multiple comparisons. We found that these networks are common in all of subjects we analyzed. 2. We found that the dynamics of these networks are different in resting state than in task based fMRI. 3. We also found these networks demonstrate gender and age interaction effects that may have important clinical implications. we are currently writing up our findings.